Host heterogeneity affects susceptibility of Babesia microti infection using vector-mediated transmission

PROJECT SUMMARY
Human babesiosis is an emerging tick-borne infectious disease in the US that is primarily caused by the
intraerythrocytic piroplasm parasite, Babesia microti (Bm). Clinical presentations of babesiosis can range from
asymptomatic or mild symptoms to severe or fatal disease. Severe disease is likely dependent on several
undefined variables including host and Bm genetics, immune status, and age-dependent variables. Several gaps
in our knowledge exist about the characteristics that define protective immunity and the contribution of host
genetics to severe Bm infection. Additionally, many studies use artificial transmission methods (needle
inoculation) that are insufficient for understanding how Bm naturally affects host health. Therefore, a significant
need exists to identify and characterize polymorphic host genes and pathways that drive variability in
tick transmitted Bm infection to better understand specific genotypic signatures linked to disease
phenotypes. The Collaborative Cross (CC) mouse resource is a vital tool to bridge the gap between host
genotype and disease phenotype by enabling high-resolution quantitative trait loci (QTL) mapping of complex
traits in both healthy and diseased individuals. Using the CC resource to link disease phenotype to genotype is
a major strength of our proposal because the genomes of these mice are fully sequenced and are easily
searchable on various online platforms, reducing the need for time consuming and costly sequencing studies. In
Aim 1, we will test the hypothesis that host genetic polymorphisms significantly impact tick transmitted Bm
infection, including parasitemia levels during acute disease, resolution of infection, and maintenance of
hemoglobin levels during infection. Furthermore, we will evaluate whether the impact of host genetics is
dependent on the route of infection (needle vs tick transmission) using CC founder strains. We expect the CC
founder strains will exhibit marked heterogeneity in disease phenotype (parasitemia and hemoglobin levels), in
response to tick transmission of Bm. In Aim 2, we will perform initial mapping of impactful QTL regions that were
found to be associated with Bm pathogenesis. CC recombinant (CC-RI/RIX) strains will be selected based on
strains that provide the most comprehensive genomic coverage of the CC founder strains and represent specific
disease phenotypes related to acute parasitemia levels, mulitiple versus single waves of parasitemia, resolution
of infection, and hemoglobin levels. We expect to detect QTLs of 10% effect size or greater based on previous
infection models using the CC mouse resource, however if this is not observed it may suggest that a large
number of genetic polymorphisms with small effect size are important for differences in Bm pathogenesis which
will be important and valuable new information. These aims are complimentary, but not dependent on one
another as our preliminary data has shown that needle inoculation has a strong impact on host genetic
polymorphisms. The use of CC mice to identify host QTLs important for regulating parasitemia is an innovative
approach that has never been applied to Bm and our findings will provide crucial insights into Bm pathogenesis.

Public health relevance
PROJECT NARRATIVE Human babesiosis, caused by Babesia microti (Bm) infection, is a malaria-like emerging tick-borne infectious disease that may cause severe clinical manifestations particularly in immunocompromised individuals and those of advanced age (i.e. over 50); however, severe disease also occurs in those with no known risk factors, indicating unknown critical determinants that contribute to susceptibility to babesiosis. In this proposal, we will use the collaborative cross mouse resource, a next-generation mouse genetic reference population created to bridge the gap between host genotype and disease phenotype by enabling high-resolution QTL mapping of complex traits, to compare the role of host genetic polymorphisms in susceptibility to Bm using two distinct routes of parasite transmission: natural horizontal tick transmission and needle inoculation. Genetic polymorphisms linked to Bm disease severity are currently unknown, deciphering these links will improve our understanding of the immunopathology of babesiosis to develop better treatment methods for humans.